Lacrimal Gland Repair Using Progenitor Cells

Lacrimal gland (LG) is an exocrine tubuloacinar gland that secretes the aqueous layer of the tear film.
Any alteration in the quantity and/or quality of tears produced by LG can result in aqueous deficiency dry
eye disease (ADDE). ADDE is a chronic condition affecting millions of Americans, with symptoms ranging
from a dry itchiness to blurred vision and accompanied by an increased risk of eye infections. Regenerative
and stem cell therapies that target LG repair are now coming to the fore, however, our understanding of LG
stem and progenitor cell biology is still incomplete. Our previous experiments on progenitor cell
transplantation label retaining cell (LRC) analysis and cell lineage tracing with clonal analyses suggest adult
LG has reserve or extremely plastic progenitor cells especially in the Sox10+ cell lineage and that LG
progenitor may have a therapeutic role in ADDE. Our recent studies demonstrate that myoepithelial cells
(MECs) retained high level of plasticity and are able to differentiate into acinar cells upon LG injury or
transplantation. Moreover, genetic elimination of MECs in vivo showed that they are required for LG
progenitor and acinar cell function. We also showed that LG inflammation could be mediated by the
Pannexin-1 (Panx1) membrane channel glycoprotein - a key regulator of inflammasome assembly.
Inflammasomes are large intracellular multiprotein complexes that activate proinflammatory cytokines in
response to infection and tissue damage or chronic inflammation. Our study suggests that the epithelial
cells sense damage/inflammation and contribute to the inflammatory response by producing the pro-
inflammatory cytokines interleukin-1 Beta(IL-1Beta) and IL-18. Moreover, we showed that blocking pannexin-1
(Panx1) or Caspase 4 in LG reduces pro-inflammatory cytokine release and improves transplanted cell
engraftment. In a new proposal we will study the molecular and cellular nature of LG progenitor and
surrounding differentiated cells in healthy and chronically inflamed LG. First we will evaluate the Sox10+
(MEC and acinar) lineage establishment in healthy and diseased LGs and investigate the role Sox10
expression in Krt5 expressing progenitors in establishment of the MEC lineage. Second, we will investigate
the role of inflammasome pathways in LG progenitor and other epithelial cell function and LG repair in SS
mouse models Third, we will use a combination of anti-inflammatory Panx1 pathways blocking therapies
and cell transplantation for LG repair. We expect to identify key mechanisms responsible for LG dysfunction.
Our analysis of inflammasome pathways may facilitate development of entirely new drug treatments for
ADDE. Our studies will also provide important enabling information for use of LG progenitor cells in cell
replacement therapy for dry eye diseases that have no effective treatment or cure.

Public health relevance
This proposal will provide new understanding of the progenitor cell function in homeostatic and diseased LGs. Our study will provide new information how lacrimal gland epithelial and progenitor cells sense inflammation and contribute to development of dry eye condition. We are confident that our new approach targeting inflammasome pathway and lacrimal gland progenitor cells will lead to development of a new therapies that improve lacrimal gland function during chronic inflammation.